Radical-Mediated Atom-Transfer Strategies for Chemical Synthesis

Schmidt – Project Summary
Radical species play important roles in biological systems linked not only to dysfunctional cell proliferation and
other disease pathways, but also in essential healthy processes necessary for life. Understanding the reactivity
profiles of open-shell carbon, oxygen, sulfur, and other heteroatomic-centered radical intermediates is crucial to
understanding how these processes occur and to propose reasonable mechanisms for currently ill-defined
pathways.
Studying and understanding reactivity profiles of radical intermediates can also result in the development of new
synthetic methodologies with the potential to streamline and make the synthesis of existing pharmaceuticals
more efficient and provide access to the next generation of therapeutics and tools for imaging, diagnosis,
treatment, and prevention.
This proposal is built on the prior and concurrent efforts of the PI’s research group using phosphorous-based
reagents to unmask carbon and heteroatom-centered radicals from untraditional precursors. This general
platform has achieved the regioselective construction of C-N bonds which are present in a substantial portion of
FDA approve pharmaceuticals and are often involved in the mode of biological activity. These radical-mediated
approaches leverage the favorable thermodynamics of atom-transfer processes to achieve new bond formations
from common chemical functionalities. Future studies will continue to explore the potential of this general
platform by investigating the ability of other common functional groups to be analogously unmasked to achieve
new bond formations. We anticipate that this work may lead to new strategies in complex molecule construction
for use in the preparation of new molecular therapeutics and tools in chemical biology.

Public health relevance
Schmidt – Project Narrative Reactive radical species are responsible for essential biochemical processes and are implicated in various disease pathways making the Investigation of fundamental radical reactivity-selectivity profiles essential to understanding the chemical underpinnings of these vital systems. This work proposes to investigate the reactivity of carbon, oxygen, and sulfur-centered radicals with reduced phosphorous-based reagents. Additionally, this work will lead to the development of new synthetic methods with potential applications in the preparation of pharmaceuticals and new molecular tools in chemical biology.